Computational methods for multiplex image analysis of the tumor microenvironment

PROJECT SUMMARY
Spatial biology techniques, such as multiplex immunofluorescence (mIF) imaging, enable detailed molecular
profiling of tissue microenvironments while preserving spatial context. These techniques hold tremendous
potential in basic research and personalized medicine, but the complexity of the resulting data necessitates
carefully-designed computational methods to fully leverage this potential. Such approaches are especially
needed for studying the tumor microenvironment, where both the cellular composition and spatial structure
may play a critical role in patient outcomes. Our project will combine a unique mIF dataset with
biologically-informed computational methods to further our basic understanding of the tumor microenvironment
and identify patterns that can ultimately inform new treatment strategies. The dataset is derived from a
clinically validated mIF assay that was performed prospectively across a real-world cohort of 2,032 patients
encompassing over 20 cancer types. We will develop several complementary computational strategies tailored
to multiplex images, ranging from spatial statistical methods to uncover tumor phenotypes in an unsupervised
fashion, to deep learning models trained to directly predict patient outcomes. Importantly, the methods are
designed with interpretability in mind, offering opportunities to identify spatial biomarkers associated with tumor,
genomic, and clinical factors. Towards improved scalability, we will also develop deep learning approaches to
predict mIF-based phenotypes from routine histopathology slides. The strategies developed in this project will
be broadly applicable across spatial biology applications, and we will make these tools freely available to
support other researchers.

Public health relevance
PROJECT NARRATIVE The environment in which a tumor develops contains a milieu of different cell types arranged in complex spatial patterns, where these features may play a critical role in cancer progression and treatment response. We will develop computational strategies rooted in spatial statistics and deep learning to analyze detailed images of these tumor microenvironments. This analysis will deepen our understanding on the spatial structure of tumors and identify patterns that could facilitate individualized treatment decisions.